ALCOHOLISM IN NATIVE AMERICANS

This study examines quantitative aspects of the response to alcohol in American Indians and relates these to the genotype for alcohol and aldehyde dehydrogenase as well as the quantity/frequency of alcohol drinking behavior and family history of alcoholism.